Mapping host-microbe-metabolite interactions in 3D to find diet-derived enhancers of immunity

Project Summary
Antimicrobial resistance is an increasing problem, and current drug pipelines are not keeping pace with the rise
of antimicrobial resistance. An alternative strategy is to boost host immunity. An often overlooked side-effect of
the vitamin and mineral supplementation projects of the 1940s is that these supplements greatly reduced
infectious disease burden. Recent work has shown that further gains may be possible, especially in adding
phytochemicals back to highly processed diets typically consumed in the United States. However, we lack a
fundamental understanding of how these components are processed by the microbiome, and how diet-derived
molecules, microbiome and host immune system work together to resist infectious disease.
A key barrier preventing us from making these discoveries is that each individual assay (microbiome, host
gene expression metabolome, dietary compounds) is expensive and highly multivariate. Three key insights that
enable the current project are the miniaturization of DNA and RNA sequencing assays on advanced nanoliter-
scale liquid handling robots, greatly reducing the cost, the combination of untargeted and targeted mass
spectrometry on the same samples in high throughput to enable discovery of a much greater chemical space,
and the ability to use explicitly spatial maps on multiple scales to integrate the dataset throughout the body and
enable both visual analytics and deep learning approaches based on spatial data. These breakthroughs will
provide a fundamentally new understanding of how dietary metabolites promote disease resistance, and will
allow us to develop a new infrastructure to integrate results from many investigators in different laboratories
studying various aspects of these systems. Additionally, the results will allow us to choose biomaterials and
biomarkers in human subjects that provide maximum information about internal nutritional and immune status.
Results will be tested against the NHANES and American Gut cohorts.
The results of this project will therefore be: 3D maps of mouse models showing how the microbiome, diet, and
host gene expression produce immunity; an infrastructure for creating and sharing these maps; and a
preliminary test of whether the results extend to large human populations.

Public health relevance
Project Narrative The public health relevance of this proposal is that it will provide an infrastructure for analyzing impacts of dietary components and microbiomes throughout the body. The analysis of these maps will help us identify dietary components that improve resistance to infectious disease.